SC56835 FOR TREATMENT OF OSTEOARTHRITIS AND RHEUMATOID ARTHRITIS

Evaluate safety, including incidence of significant gastrointestinal events, of drug for up to two years in patients with osteoarthritis or rheumatoid arthritis. Evaluate long term efficacy and document long term inpact of drug on utilization of health resources and quality of life.